Core B: Animal Models

CORE B – ANIMAL MODELS
PROJECT SUMMARY
Primary ciliary dyskinesia (PCD) is an autosomal recessive disease caused by mutations in the genes that
encode cilia structural proteins. Mutations in the DNAI1 gene are common in people with PCD and
characterized by loss of the outer dynein arm (ODA) of the cilia and loss of ciliary beating. Airway infection
and inflammation in both upper and lower airways are present in people with PCD and often lead to respiratory
failure. Although several therapies have improved the lives of patients, current treatments are inadequate and
PCD remains a lethal disease. Our knowledge about the pathogenesis of the disease, its progression, and the
state of the neonatal lung is inadequate. These gaps in our knowledge have hindered attempts to develop
better treatments and preventions of lung disease. A major impediment to addressing these issues had been
limitations of animal models. We generated PCD pigs that replicate the key features of human PCD disease
including early sinus abnormalities (mucosal thickening and mucus impaction), early airway abnormalities (air
trapping, lobar collapse, thick abnormally elastic mucus), and early infection and inflammation. The goals of
the Animal Models Core will be to: (1) Provide Program investigators with WT and PCD pigs so that they can
successfully complete their project aims; (2) Assist projects in the harvesting of biologic samples from live
animals (e.g., bronchoalveolar lavage fluid and blood), the care and analysis of study animals, record keeping,
and coordination of animal usage among projects; (3) Provide scientific support, expertise, and resources for
acquisition of image datasets and subsequent analysis; and (4) Help Project Leaders successfully accomplish
the aims of their Projects. State-of-the-art image acquisition technology and analysis tools are readily available
at the University of Iowa for these Projects. The Animal Models Core will function seamlessly through already
established interactions with the Project Leaders and Core Directors. The success of the Animal Models Core is
ensured because of the commitment, experience, and expertise that the personnel bring to the Core.

Public health relevance
CORE B – ANIMAL MODELS PROJECT NARRATIVE There is no Narrative for the Animal Models Core.